Cr(VI) exposure and skeletal muscle differentiation and regeneration

SUMMARY
Hexavalent chromium, Cr(VI), is widely used in industrial processes such as stainless steel production,
electroplating, textile manufacturing, wood preservation, and leather tanning. Occupational or environmental
exposures to Cr(VI) have been associated with a variety of adverse respiratory, cardiovascular, gastrointestinal,
hematological, and hepatic effects. However, very little is known about the impact of Cr(VI) on skeletal muscles,
the largest organ in the human body comprising about 40% of body mass. The 3-month toxicity study by National
Toxicology Program (NTP) reported a dose-related increase of serum creatine kinase (CK) activities in both male
and female rats exposed to Cr(VI) via drinking water compared to the control group, indicating muscle injury.
Consistently, a significant increase of serum CK activity has been reported in chrome plating workers compared
to the control subjects. Despite a clear sign of muscle injury has been reported in both human and animal study,
the impact of Cr(VI) exposure on muscle injury and regeneration is completely unknown. Our recent study reveals
that acute exposure of mouse C2C12 myoblast cells to Cr(VI) inhibits myogenic differentiation in a dose-
dependent manner. Additionally, Cr(VI) inhibition of myogenesis is further confirmed in freshly isolated mouse
primary myoblasts ex vivo. Moreover, the expression of key myogenic regulatory factors (MRFs) was significantly
altered in Cr(VI)-treated cells. Taking together, our results demonstrate an inhibitory effect of Cr(VI) in myogenic
differentiation in vitro and ex vivo. Given that in vitro myogenic differentiation largely recapitulates in vivo
myogenesis during early embryo development and adult muscle regeneration, we hypothesize that Cr(VI)
adversely affects skeletal muscle development and regeneration in vivo. In this proposal, we aim to address
whether Cr(VI) lead to defective myogenesis and impaired muscle regeneration with the following specific aims.
First, we will examine the effects of acute or chronic Cr(VI) exposure on adult muscle injury and regeneration in
vivo. Second, we will explore the impact of Cr(VI) on skeletal muscle development by assessing primary and
secondary myogenesis in mouse embryos prenatally exposed to Cr(VI). Lastly, to elucidate the mechanism
underlying Cr(VI) inhibition of myogenic differentiation, we will analyze the role of MyoD and Myf5 in Cr(VI)-
induced defective myogenic differentiation, and explore whether special AT-rich sequence-binding protein 2
(Satb2), a known Cr(VI) target gene in lung carcinogenesis, acts as an important target or a functional mediator
of Cr(VI) in myogenic differentiation. The success of the proposed research will generate valuable evidence to
support the adverse impact of Cr(VI) on skeletal muscle development and regeneration, and promote more
epidemiological research on Cr(VI) exposure as a significant risk factor for skeletal muscle health.

Public health relevance
PROJECT NARRATIVE: Environmental or occupational exposures to hexavalent chromium Cr(VI) have been associated with a number of adverse health effects; yet, little is known about its impact on skeletal muscles. This proposal aims to investigate the effect of Cr(VI) exposure on myogenic differentiation and muscle regeneration. The success of the proposed research will generate valuable evidence to support Cr(VI) exposure as a risk factor for muscle impairment, and provide additional insights on prevention and therapeutic approaches for muscle-associated disease.